Hippocampal network mediating behavioral effects of social isolation in mice

Project Summary
Major depressive disorder is a prevalent and debilitating mental illness associated with a high personal and
socioeconomic burden, impacting nearly 10% of Americans. Depression is typically associated with decreased
social interactions and reduced interest in novel events. Despite the widely accepted role of the hippocampus
in depression, there remains no clear understanding or prevailing theory regarding how hippocampal function
changes in this condition, nor is it understood how, or if, the rapid-acting antidepressant ketamine influences
these hippocampal processes. The proposed research aims to address these issues using a novel
hippocampal slice preparation to assess signal transformation across the polysynaptic prime hippocampal
circuit and measure disrupted sociability and interest in social novelty as an index of depression-like behavior.
The research will test the overarching hypothesis that lack of sociability and interest in social novelty is
associated with impairments in hippocampal network function and that these changes can be offset by
ketamine treatment. This hypothesis is supported by robust preliminary results showing that a short period of
single housing of rodents still living in a busy colony produces impaired social behavior and disrupts
hippocampal circuit function (i.e., reduces spontaneous sharp waves and hippocampal prime circuit
throughput). Importantly, a single dose of ketamine normalizes measures of hippocampal circuit function and
social behavior as assessed 6 hours post-treatment. Proposed studies will further validate these preliminary
results in male and female mice and test if this lack of sociability and interest in social novelty quantified
through the 3-Chamber Social Preference Test reflects changes in reverberatory activity in hippocampal field
CA3, and if silencing of CA2 in wild-type rodents reproduces a similar behavior phenotype to single-housed
animals as well as disrupts hippocampal throughput. Specifically, Aim 1 will test if a period of single housing
leads to impaired social behavior and disruptions in hippocampal circuit function and if these changes are
alleviated by ketamine treatment. Aim 2 will then test if partial chemogenetic (DREADDi) suppression of
reverberatory activity in field CA3 replicates the effects of social isolation on mood and behavior, and if these
measures are normalized by ketamine treatment. Together, this proposal will provide the first description of
changes in hippocampal circuit function associated with the depression-like symptom of lack of sociability and
interest in social novelty with novel insight as to why ketamine is an effective therapeutic. Importantly, these
studies may identify a narrow cellular basis of hippocampal circuit dysfunction and, thus, a high-priority target
for effective therapeutics.

Public health relevance
Project Narrative Depression is a prevalent and debilitating mental disorder, yet despite intense research interest, there remains a poor understanding of the neurobiological basis of both the underlying disorder and the actions of current therapeutics. Proposed studies will test the hypothesis that depression-like symptoms, such as lack of sociability and interest in social novelty, arising from single housing of rodents, are associated with specific disturbances in hippocampal network activity that are offset by treatment with the rapid-acting antidepressant ketamine. Results from these studies will significantly advance our understanding of how changes in hippocampal network activity contribute to depression and why ketamine is an effective therapeutic.